Genetic Biochemical Studies of Signaling in Growth and Acclimation

The long-term goal of this project is to understand the molecular networks through which
hormones, environmental signals, and nutrients together control plant growth and development. As
sessile organisms, plants have evolved complex and robust cellular signaling systems to regulate
growth and metabolism according to internal status and environmental conditions. Dissecting these
plant regulatory systems not only is important for crop resilience and food security but also can
improve human health, as many signaling mechanisms are highly conserved in plants, humans,
and human parasites. This research project aims to dissect the cellular signaling and regulatory
networks that integrate hormonal, metabolic, and environmental signals. To gain a comprehensive
understanding of the complex system, we integrate a broad range of research approaches
including genetics, genomics, proteomics, structural biology, cell biology, and chemical proteomic
approaches. We also use both muti-cellular and single-cellular model systems (Arabidopsis and
Chlamydomonas) to gain insight into the conserved mechanisms such as cell cycle regulation and
the evolution of inter-cellular signaling mechanisms underlying cell-cell communication,
development, and morphogenesis. In the past two decades, we have elucidated molecular
mechanisms by which the brassinosteroid (BR) hormone acts through the cell surface receptor
kinase BRI1 and its downstream phosphorylation cascade to regulate gene expression and plant
growth, cross-talks with other signaling pathways to regulate development and environmental
responses, and intersects with sugar-signaling pathways to optimize growth and acclimation. We
have also discovered signaling mechanisms that regulate cell division, elongation, differentiation,
and innate immunity. Furthermore, we have recently generated proteomic maps of the
nutrient/sugar-sensing O-glycosylation (O-GlcNAc and O-fucose) pathways and discovered their
convergence with the BR-regulated phosphorylation pathway. Our research elucidates a signal-
processing network that controls plant growth according to nutrient/sugar availability, hormonal
instructions, and environmental cues, and increases our molecular insight into signaling
mechanisms involving protein-protein interactions and protein modifications by phosphorylation
and glycosylation. We focus on proteins that are conserved in humans or human parasites, and
thus our research also informs medical research. Our research will benefit human well-being by
improving food security, environmental sustainability, and drug development/discovery.

Public health relevance
Project Narrative The core signaling mechanisms that regulate basic cellular functions, such as cell division, metabolic homeostasis, and subcellular structural organization, tend to be highly conserved in all eukaryotes, whereas diverse mechanisms of intercellular communication have evolved to support different morphologies and lifestyles of different organisms. Investigation of signaling mechanisms in plant model systems is not only important for agriculture, food security, and ecosystem sustainability but also can inform medical research because many plant signaling components are conserved in humans and Apicomplexa which includes parasites responsible for serious human diseases, such as malaria and toxoplasmosis.